Montana IDeA Community Engagement Core

The Center for American Indian and Rural Health Equity (CAIRHE) achieves its research mission through
multidisciplinary community-based participatory research (CBPR) that is considerate of and consistent with
communities' cultural beliefs. Community involvement in every phase of the research, from design to
dissemination, results in the most effective inquiry and intervention because the greatest knowledge of the
health disparities plaguing our frontier region resides in the communities themselves. Since its inception, the
Center has relied upon strong community engagement to build effective community-investigator partnerships
across Montana, including seven American Indian reservations and many isolated rural areas, and to train
investigators in best practices of CBPR. CAIRHE has developed a growing network of communities, health
care providers, public health agencies, and other stakeholders working together to improve health outcomes
for Montana's most at-risk populations. During COBRE Phase I, CAIRHE and two other Institutional
Development Award (IDeA) programs at MSU, Montana INBRE and the American Indian/Alaska Native Clinical
and Translational Research Program (CTRP), formed the innovative Montana IDeA Community Engagement
Core (CEC). Through shared resources and cross-program collaboration, the CEC eliminates redundancy
among the three IDeA programs, and it enables cost efficiencies and more conscientious stewardship of
taxpayer resources. Most importantly, an effective Core is an indispensable part of the Center's overarching
aim to be the state and regional leader in multidisciplinary, community-based health equity research, thereby
improving the health of rural and Native communities across the Rocky Mountain West. Continuing throughout
Phase II, CAIRHE will contribute to the success of this Core through its support of Community Research
Associates, development of Community Advisory Boards, funding of faculty training and mentoring, and
maintenance and management of the Core's Community Engagement and Research Mobile Lab. Specifically,
the Core will continue to build multisector community-investigator partnerships across the state. It will increase
community capacity for CBPR partnerships and health equity research through community facilitation and
training. The Core also will increase understanding of CBPR, community needs, and historic trauma through
investigator training in areas of expertise shared by its staff of Community Research Associates. The Core's
use of the Mobile Lab will increase research partnerships and understanding in remote communities in one of
the most rural states in America. And the Core will increase CAIRHE's impact statewide and across the
country through research dissemination. With the full cooperation of the Center's community and stakeholder
partners, the Core will help CAIRHE share its successful research outcomes and interventions so they can be
replicated in other communities facing similar health equity challenges.